Charting Positive Valence Systems Trajectories in Offspring of Depressed Mothers to Predict Internalizing Symptoms in Early Childhood

PROJECT SUMMARY
Offspring of mothers with depression are 2 to 3 times more likely than offspring of never-depressed mothers to
develop anxiety and depressive disorders. Meta-analytic work shows that relations between maternal
depression and offspring internalizing symptoms are stronger in younger than older children, highlighting the
critical need to study causal risk mechanisms early in development among these high-risk (HR) youth to
develop targeted prevention efforts. Across studies, HR youth are characterized by alterations within the NIMH
Research Domain Criteria (RDoC) construct of Positive Valence Systems (PVS). Specifically, reduced reward
responsiveness (RR), a PVS subconstruct, is consistently observed across behavioral and brain units in HR
youth and predicts internalizing symptoms during adolescence, suggesting that reduced RR represents a key
vulnerability marker to target with prevention efforts for HR youth. Yet, previous research in this area has
focused predominantly on adolescent samples despite increasing evidence that PVS impairments are apparent
in preschool-aged youth across internalizing disorders. Prior studies examining PVS function in HR samples
are also largely limited by a single PVS assessment, limiting our understanding of how maternal depression
impacts both overall levels and trajectories of PVS function in offspring during early development. To address
these gaps, we will use an innovative, multimodal, accelerated longitudinal design to chart trajectories of PVS
function across early childhood in a large sample (N=450) of biological offspring of mothers with and without
depression histories recruited across two sites. Children, ages 4-6 at baseline, will complete developmentally
sensitive tasks evoking neural (event-related potentials) and behavioral indicators of RR to tangible and social
rewards at baseline and 1- and 2-year follow-ups, resulting in trajectories of PVS function from 4 to 8 years.
We will assess factors that protect against or exacerbate alterations in PVS development to identify HR youth
who could most benefit from PVS-related interventions. Specifically, our data suggest that maternal positive
emotion behaviors (i.e., positive affect, parenting, and socialization) can buffer against maternal depression
effects on child PVS function, whereas exposure to early life adversity (ELA), particularly deprivation
experiences, potentiates effects. Thus, maternal positive emotion behaviors and child ELA exposure at
individual and community-levels will be assessed at every time point, along with parent and clinician-rated
assessments of child’s internalizing symptoms and disorders. This unique design will allow us to examine the
effects of maternal depression on overall PVS levels and developmental trajectories in offspring during early
childhood (Aim 1), test PVS function as a mechanism of maternal depression effects on early-emerging
internalizing symptoms (Aim 2) and examine key risk and protective factors that moderate effects of maternal
depression on child PVS function (Aim 3). Findings from the project may lead to novel PVS prevention efforts
that could be delivered during early child development to break intergenerational risk cycles more effectively.

Public health relevance
PROJECT NARRATIVE Maternal depression is a robust predictor of internalizing symptoms and disorders in offspring, highlighting the public health importance of studying causal risk mechanisms early in development to inform targeted prevention efforts at the earliest possible point. The current project combines behavioral and neural measures across 3 time points spanning ages 4 to 8 years to examine how developmental trajectories of reward responsiveness shape early internalizing symptoms among offspring of depressed mothers. By examining how maternal positive emotion behaviors and child early life adversity impact these pathways, findings from the current study have significant potential to inform novel prevention targets for specific populations of at-risk youth.